Core--Research Services

The specific aims of the Research Services Core are: 1. To provide service and support for computers, systems, networks, and software used by project investigators. 2. To provide analytical and statistical consultation to project investigators and associated fellows. 3. To furnish and maintain equipment and facilities for chronic animal monitoring. 4. To furnish and maintain equipment and facilities for microscopy, histology and image processing. 5. To develop, modify, and support electronic and mechanical instrumentation in support of proposed research. 6. To provide support for rat colony maintenance and distribution of the SS, SS-13BN, and BN rat strains.